Targeting succinyl-CoA:glutarate-CoA transferase as a novel therapeutic strategy for glutaric aciduria type 1

Project Summary / Abstract
In this project, the investigators propose to study and validate the enzyme succinyl-CoA:glutarate-CoA
transferase (SUGCT) as a novel pharmacological target for the treatment of glutaric aciduria type 1 (GA1). GA1
is an autosomal recessive inborn error of lysine, hydroxylysine and tryptophan degradation. Patients can present
with brain atrophy and macrocephaly, and may develop dystonia after acute encephalopathic crises that lead to
striatal degeneration. The disorder is caused by a deficiency of the enzyme glutaryl-CoA dehydrogenase
(GCDH), which leads to the accumulation of neurotoxic metabolites such as 3-hydroxyglutaric acid. GA1 is
considered a treatable disorder and therefore included in newborn screening programs in many countries.
However, current treatment consists of dietary intervention, carnitine supplementation, and emergency treatment
which requires intense efforts from both caregiver, patient and clinical team. It must be meticulously maintained,
but even so neurological disease still develops in 25% of patients, with these negative outcomes reflecting
historical health inequities and social determinants of disease. Thus, the treatment needs of GA1 patients are
unmet. Development of pharmacological therapies, however, is hampered by limited understanding of
pathophysiological mechanisms. The biochemical phenotype of the GA1 mouse model is similar to that of human
disease. High lysine exposure of GA1 mice is necessary to induce a clinical phenotype resembling human GA1,
but the susceptibility is variable and a significant number of mice remain asymptomatic. Although the genetic
background of the mouse model is known to be one of the main modulating factors, the underlying molecular
mechanism has previously remained unknown. The investigators have now found that SUGCT, an enzyme
directly involved in the metabolism of glutaryl-CoA, is polymorphic between relevant mouse strains, which
explains the difference in vulnerability to high lysine exposure. Based on published and preliminary data, the
investigators hypothesize that pharmacological SUGCT inhibition is a novel therapeutic option for GA1.
The overall objective of this R01 proposal is to further validate SUGCT as a novel therapeutic target for the
treatment of GA1 and to develop selective small molecule SUGCT inhibitors to provide pre-clinical proof-of-
concept. In order to reach this objective, the investigators propose the following three specific aims. In AIM 1,
the investigators will establish the functions of SUGCT through biochemical, cell line and structural biology
studies. In AIM 2, the investigators will validate SUGCT as a drug target in GA1 mice through the generation of
whole body and tissue-specific Sugct KO mice. In AIM 3, the investigators will identify SUGCT inhibitors through
a high-throughput small molecule screen (HTS) and further validate current in-hand hits and new ones through
medicinal chemistry. The ultimate goal of this project is to better understand the pathophysiology of GA1 and
provide a novel path toward finding pharmacological treatment options for affected patients.

Public health relevance
Project Narrative Glutaric aciduria type 1 is a genetic disease of amino acid metabolism. This disorder has been included in newborn screening programs, but the treatment needs of patients are unmet. The investigators are studying a novel drug target to treat glutaric aciduria type 1, which will lead to both increased understanding of disease processes and potential new therapeutic molecules.